IN VIVO STUDIES OF IBUPROFEN IN PATIENTS WITH CYSTIC FIBROSIS

This is a bronchoalveolar lavage and mouth wash study to test the hypothesis that ibuprofen limits the inflammatory response in the CF lung by reducing persistent neutrophil influx due to limiting LTB4 production by neutrophils already recruited to the CF lung. Results from the BAL portion of the study revealed decreased inflammation in the airways of CF patients randomized to ibuprofen compared to those randomized to placebo. Mouthwash studies revealed that high-dose ibuprofen decreases PMN delivery to the oral mucosa, while low-dose ibuprofen increases PMN delivery, in both CF patients and healthy volunteers. Since the results of the 4-year trial suggest that ibuprofen should become a standard component of CF care, an expansion of the original study has been designed to include intermediate doses of ibuprofen and a slightly longer duration of drug administration, and to obtain ibuprofen levels during the study. The specific aims are 1) to determine the effect of ibuprofen on PMN delivery to a mucosal surface in CF patients and healthy controls and 2) to determine the duration of effect (and possible rebound effect) of ibuprofen on PMN delivery to a mucosal surface (the oral mucosa) in CF patients and healthy controls.